CORE GRANT FOR VISION RESEARCH

Overall Project Summary
The overall mission of the proposed Vision Core is to continue to enhance vision research at Harvard by providing
vision scientists with resources and facilities that could not be supported by individual laboratories. Specifically,
the structure and operation of the Vision Core have been designed around three key objectives: (1) the design,
optimization, and manufacture of custom equipment and reagents for investigators; (2) the dissemination and
teaching of new methods and approaches for vision studies through a community of systems and cellular
neuroscientists, engineers, machinists, and biologists; and (3) the seeding of new collaborations through the
transfer of ideas and experimental strategies among investigators. In this capacity, the Vision Core grant
currently supports 17 vision research labs at Harvard with 21 qualifying NEI awards.
In support of these goals the proposed Vision Core includes three modules, and has undergone a major
restructuring since the last funding period in response to the needs of vision researchers at Harvard. A newly
merged Neuroengineering and Fabrication module will provide hardware and software solutions to the vision
research community. A Viral Module supports critical anatomical and functional experiments using viral
constructs and will enhance the range of vision research supported by the Core. Lastly, a newly proposed
Computational Module will provide expertise and dedicated computing power to develop and train new
algorithms to test theories of vision science. Each module is under the direction of an accomplished and capable
faculty member that studies vision, and experienced staff that run the module on a day-to-day basis, overseen
by the Administrative Core. Harvard Medical School has provided significant institutional support for these
modules in the form of space, renovation costs, internal grant support for equipment and operational costs, and
financial administrative support; however, continued external support of the Harvard Vision Core is essential for
maintaining a high level of productivity in the vision community at Harvard, fostering and supporting collaborative
efforts, and attracting new scientists to vision research.

Public health relevance
Overall Project Narrative Recent technological advances in neuroscience have presented new approaches for vision researchers, in addition to challenges in terms of available access and expertise. The Harvard Vision Core plays a central role in vision research in the Harvard community by providing services, equipment, and training to over 20 vision research laboratories. The Core also brings vision scientists together by providing a collaborative environment for research and for training the next generation of vision scientists, and, in this way, the Vision Core at Harvard Medical School accelerates the pace of our understanding and treatment of dysfunctions of the visual system.